Education Pathways for Biomedical Data Science (R25)

Project Summary / Abstract
This project brings together Drexel University and the Children’s Hospital of Philadelphia (CHOP) to create an
adaptive Biomedical Data Science education program to empower researchers to learn and use emerging data
science methods. We propose an in-line program to prepare researchers for data-driven work directly in their
current field, while also identifying avenues for interdisciplinary collaboration. We will develop novel curricula
pathways, leverage existing educational resources, create bridge materials, and provide practicum “lab”
activities matching domain-specific projects to participants for hands-on experience.
Educational Pathways in Biomedical Data Science will collaborate with the CHOP Office of Academic Training
and Outreach Programs to engage a diverse learner audience in novel pedagogical research. Learners will be
recruited from active participants in many existing CHOP training initiatives, including a novel data science
education program, graduate student training, postdoc mentorship, physician fellowship research, and clinical
research staff training. After enrollment, education program managers will cluster participants into collaborative
communities of practice where they will receive mentorship and contribute to development of pathways.
We acknowledge that we are still learning the most effective interventions for biomedical data science
education, both within our specific communities and broadly within medical education (e.g. Federer et al.,
2015; Rowhani-Faarid, Allen, and Barnett, 2017). We will develop new evidence of gaps in knowledge, skills,
and attitudes among learners.
We will develop and implement biomedical data science literacy instruments
based on emerging scholarship. We will also gather learner feedback via mixed methods to adapt and evolve
our modular resources, ensure robust learner outcomes, and align deliverables with the NIH Strategic Plan for
Data Science.
Data Science instruction for researchers outside of traditional computer and information sciences is a concrete
step toward data-driven scientific literacy for all. We will ensure that participants emerge from this program with
computational and algorithmic literacy solidified through hands-on experience. For non-computing researchers,
we also will provide the foundational data fluencies necessary for individuals to contribute meaningfully to
machine learning research, which will enable data-driven systems, insight-to-decision transformation, decision-
making, and data-driven decision management. Finally, for all participants, we will strive to help individuals
from a broad spectrum of backgrounds and identities identify new directions in which to develop their careers.

Public health relevance
Project Narrative “Educational Pathways in Biomedical Data Science” will create evidence-based pathways to guide and augment researcher skill in data-intensive science. Our learning pathways and supporting modules will equip researchers to perform nimble research with massive datasets that span institutional and disciplinary boundaries. We will model cross-disciplinary collaboration by building upon an existing partnership between the College of Computing and Informatics of Drexel University and the Research Institute of the Children’s Hospital of Philadelphia, grounding the project in both computing and biomedical research practice.